Microfluidic Impedance Red Cell Assay (MIRCA) for Emerging Pharmacologic and Gene based Therapies for Sickle Cell Disease

PROJECT SUMMARY
Acquired or inherited diseases can alter the red blood cell (RBC), causing severe clinical complications
affecting the vasculature and organ health. Inherited red cell disorders, renal failure, diabetes, and blood bank
storage lesions can all produce stiff, non-deformable RBCs. Red cell stiffness is particularly problematic in sickle
cell disease (SCD), a debilitating inherited blood disorder. An estimated 100,000 individuals in the US, and
millions more world-wide, have SCD. The field has experienced an explosion of novel SCD therapeutics,
designed to target specific individual abnormalities in the RBC in the last five years. Numerous gene-based
therapies intending to cure SCD are in clinical trials. This marked shift in SCD therapeutics produced a need for
diagnostics and analytical tools that assess RBC health and quality. We need biomarkers of red cell function to
serve as endpoints in clinical trials, assist in optimal drug selection and personalized monitoring for the individual,
and to determine if gene-based therapy has normalized the red cell. Many aspects of the red cell must be
assessed, but a key feature is deformability. There is a lack of robust, inexpensive devices sensitive enough to
capture small populations of poorly deformable red cells able to continue to hemolyze, damage the blood vessels,
and cause organ damage and early mortality. It is essential that we vet therapies for their ability to normalize the
entire population of red cells. Here we propose to develop and translate the Microfluidic Impedance Red Cell
Assay (MIRCA) to functionally measure red cell deformability, reported as Occlusion Index (OI) of a biomimetic
microcapillary network array on a chip. We propose an innovative approach and a novel collaboration between
engineers and a hematology-trained physician scientist. We will do so with the following steps:
1. We will achieve instrumentation and analytical validation of MIRCA measurement of red cell OI. Analytic
validation will be performed both in PI’s laboratory (Dr. Umut Gurkan, CWRU) and in Co-I’s hematology
laboratory (Dr. Vivien Sheehan, Emory) to prove generalizability and permit stakeholder feedback and design
modification.
2. We will clinically validate MIRCA by assessing the association between OI and clinical complications and
traditional laboratory measures of disease severity in SCD.
3. We will expand the use of the optimized MIRCA to the clinical space by demonstrating its prognostic value
in longitudinal assessments of patients with SCD experiencing clinical complications and transitions in
therapy.
Using our unique collaboration between biomedical engineers and a hematology trained physician-scientist,
we will optimize, validate, and achieve clinical adoption of MIRCA technology in clinical trials and patient care
for individuals living with SCD in the US and world-wide.

Public health relevance
PROJECT NARRATIVE Malaria, renal failure, diabetes, inherited red cell disorders such as sickle cell disease, and storage lesions of blood in transfusion medicine can all produce stiff, non-deformable red blood cells in circulation. The field of hematology lacks easy-to-use, accessible, reproducible, portable devices to evaluate red blood cell health and function in a clinical meaningful way. Using our unique collaboration between bioengineers and a hematology trained physician-scientist, we will develop, optimize, validate, and achieve clinical adoption of a new portable lab-on-a-chip microfluidic technology for assessing red blood cell health and function in clinical trials and patient care for individuals living with red cell disorders.